Changes in Neighborhood Socioeconomic Deprivation, Obesity and Diabetes

Few longitudinal studies have evaluated the relationship between change in neighborhood SES due to moving and obesity as a cardiovascular risk factor. Prior studies have been limited by use of self-reported measures of weight, use of intermediate surrogates for weight gain or cardiovascular health, small sample sizes, or limited numbers of movers. Therefore, we examined the impact of change in neighborhood socioeconomic deprivation with moving on weight change over 7 years in the Dallas Heart Study (DHS), a multi-ethnic sample of Dallas County residents aged 18-65. Body weight (kg) was measured in 2000-02 and at 7-year follow up (N=1835). Geocoded baseline and follow-up home addresses were linked to census block groups in Dallas County. A block group-level neighborhood deprivation index (NDI) was created (higher scores = more socioeconomic deprivation). Repeated measures linear mixed modeling with random effects was used to determine weight change relative to NDI change. Heckmans correction factor (HCF) was used to adjust for the non-random chance of moving to an area of higher NDI based on age, sex, race, education, income, employment, marital status, and home ownership. 49% of the DHS population moved within Dallas County during the 7-year study period. Blacks were more likely to move than whites or Hispanics (p<0.01), but there were no differences in baseline body mass index or waist circumference in movers vs. non-movers (p>0.05 for both). Adjusting for HCF, sex, race, and time-updated covariates (age, smoking, education, income, physical activity, length of residence), those who moved to areas of higher NDI gained more weight compared to those who remained at the same NDI or moved to lower NDI (0.690.29 kg per 1-unit NDI increase, p=0.02). Among those who moved, the impact of change in NDI on weight gain increased with time in the new neighborhood; mean weight gain per 1-unit NDI increase was 0.910.43 kg (p=0.03) for those living in the new neighborhood >median of 4 years, but not significant for those living in the new neighborhood median 4 years (0.550.39 kg, p=0.2). Thus, moving to a neighborhood of higher socioeconomic deprivation was associated with weight gain among DHS participants. Until economic and policy factors reduce neighborhood socioeconomic deprivation, more work is needed to identify individual or community interventions that reduce its adverse effects on cardiovascular health. In addition, we examined the relationship between neighborhood-level socioeconomic deprivation and prevalent diabetes in the DHS. Diabetes was defined by self-report, use of anti-hyperglycemic medication, or fasting glucose126 mg/dl. Logistic regression modeling was used to determine odds of prevalent diabetes for those in the highest versus lowest NDI tertile. In DHS, diabetes prevalence was 5%, 13%, and 16% across NDI tertiles (p0.001). In modeling diabetes, we found a significant interaction between race and NDI (p=0.03); therefore, models were race-stratified. White, Hispanic, and black DHS participants in neighborhoods in the highest NDI tertile were up to seven times more likely to have diabetes than those living in the lowest tertile. In Whites and Hispanics, higher deprivation remained associated with a greater likelihood of diabetes after adjustment for age, sex, smoking, and education and was only attenuated after adjusting for income. In contrast, adjustment for confounders attenuated the relationship between NDI and diabetes among blacks. Residing in socioeconomically deprived neighborhoods is associated with prevalent diabetes among whites and Hispanics in DHS. These data suggest racial/ethnic disparities in cardio-metabolic risk within areas of higher socioeconomic deprivation in Dallas County. Researchers measuring relationships between neighborhoods and health have also begun using property appraisal data as a source of information about neighborhoods. Economists have developed a rich tool kit to understand how neighborhood characteristics are quantified in appraisal values. This tool kit principally relies on hedonic (implicit) price models and has much to offer regarding the interpretation and operationalization of property appraisal data-derived neighborhood measures, which goes beyond the use of appraisal data as a measure of neighborhood socioeconomic status. We developed a theoretically informed hedonic-based neighborhood measure using residuals of a hedonic price regression applied to appraisal data in a single metropolitan area. We examined its reliability in different types of neighborhoods and correlation with other neighborhood measures (i.e., raw neighborhood appraisal values, census block group poverty, and observed property characteristics). We also examined the association between all neighborhood measures and body mass index. The hedonic-based neighborhood measure was correlated in the expected direction with block group poverty rate and observed property characteristics. The neighborhood measure and average raw neighborhood appraisal value, but not census block group poverty, were associated with individual body mass index. Therefore, we draw from theoretically consistent methodology in the economics literature on hedonic price models to demonstrate how to leverage the implicit valuation of neighborhoods contained in publicly available appraisal data. Consistent measurement and application of the hedonic-based neighborhood measures in epidemiology will improve understanding of the relationships between neighborhoods and health. Our findings suggest that researchers should proceed with a careful use of appraisal values utilizing theoretically informed methods such as the one we have developed. We also examined the relationship between neighborhood deprivation, blood pressure change, and incident hypertension in DHS. After adjusting for covariates, including moving status and residential self-selection, we observed significant associations between residing in the more deprived neighborhoods and 1) increasing blood pressure over time and 2) incident hypertension. In the fully adjusted model of continuous blood pressure change, significant relationships were seen for both medium and high deprivation. In the fully adjusted model of incident hypertension, participants in areas of high deprivation had 1.69 higher odds of developing HTN (OR 1.69; 95% CI 1.02, 2.82), as defined by 2017 hypertension guidelines. Results varied based on definition of hypertension used (pre-2017 vs. 2017 guidelines). These findings highlight the potential impact of adverse neighborhood conditions on cardiometabolic outcomes, such as hypertension. Finally, the few available population-based longitudinal studies examining the link between change in neighborhood condition and weight change to date have only examined neighborhood changes generated by residential mobility. Applying a difference-in-difference analytic framework to data from the Dallas Heart Study (DHS), a multi-ethnic, population-based cohort in Dallas County, TX, we evaluated the relationship between changes in neighborhood condition based on property appraisal data and weight change for both movers and non-movers over an approximate seven-year follow-up period. We employed a novel measure of neighborhood condition based on property appraisal data to capture temporally consistent measures of change in neighborhood condition regardless of residential mobility. We observed an inverse relationship between weight change and change in neighborhood condition which was more pronounced for non-movers (1.9 fewer kilograms gained per 1-standard deviation improvement in neighborhood condition) than for movers (1.5 fewer kilograms gained per 1-standard deviation improvement in neighborhood condition.